Nuclear Envelope Dynamics in Meiotic Quality Control

Successful sexual reproduction relies on gametes, like sperm and eggs, having exactly half the genome of
their somatic progenitor cells. This is accomplished through meiosis, a cell division process that accurately
segregates the two copies of homologous chromosomes inherited from both parents. During meiosis,
homologous chromosomes must pair up along their lengths to enable genetic crossover, which is essential for
accurate segregation. Physical pairing between homologs is usually stabilized by synapsis, where a protein
complex called the synaptonemal complex (SC) assembles between homologs along their lengths. Failure in
synapsis can lead to chromosome missegregation and aneuploidy, a major cause of birth defects such as
Down Syndrome. In diverse organisms, defects in synapsis can trigger apoptosis to eliminate the affected
meiotic cells as a quality control measure. However, the mechanisms by which meiotic cells detect and
respond to synapsis failure remain unclear. My research program will address this fundamental gap using the
highly tractable Caenorhabditis elegans germline as a model system. In C. elegans, defects in synapsis during
meiosis promote apoptosis of oocytes – precursors of egg cells. Recently, we discovered a critical role of the
oocyte nuclear envelope (NE) in apoptosis when synapsis fails. By developing and deploying a new chemically
induced proximity (CIP) tool, we discovered that following synapsis failure, the Polo-like kinase PLK-2 is
recruited to the oocyte NE to phosphorylate and destabilize the nuclear lamina. Unexpectedly, we found that
the mechanosensitive ion channel Piezo, which typically functions at the plasma membrane, also localizes to
the oocyte NE and is required to transduce this signal to promote apoptosis. This is the first evidence of
mechanosensitive ion channels in transducing a signal that originates in the cell nucleus. Now, by combining
cell biology, genetics, engineering, and other approaches, my lab will elucidate how the dynamic NE integrates
mechanical and chemical signals to regulate quality control in developing oocytes, focusing on three distinct
but complementary projects. First, we will determine the mechanisms by which Piezo channels function at the
NE. Second, we will interrogate how different signaling pathways are coordinated at the NE to regulate oocyte
development, leveraging our recent understanding of the mechanics of meiotic nuclei. Third, we will explore
the evolutionary conservation and divergence of NE-based meiotic quality control using Pristionchus pacificus,
a nematode with meiosis more similar to mammals than C. elegans. By studying nematode meiosis as a
model, the questions we seek to address are at the nexus of basic cell biology, genetics, and development. As
PIEZO2 is enriched in human oocyte-containing follicles, we expect that our research will uncover conserved,
fundamental principles underlying the accurate transmission of genetic material during sexual reproduction.
Our findings will also impact a wide range of cell biology problems related to nuclear envelope dynamics.
Additionally, new tools we develop will be broadly applicable to probe diverse cellular processes in vivo.

Public health relevance
Project Narrative: Meiosis is a specialized cell division process that produces sperm and eggs by precisely dividing the parental chromosome numbers in half. In humans, errors in this process generate eggs with an abnormal number of chromosomes and are the leading causes of infertility, pregnancy loss, and birth defects. The research proposed here addresses the fundamental mechanisms at the nuclear envelope by which cells implement quality control to ensure error-free meiosis and will have broad impact on understanding age-dependent oocyte quality decline, as well as nuclear envelope dysfunctions that lead to a wide range of human diseases including cancer and laminopathy.